Genetic and molecular regulation of experience-dependent structural plasticity

PROJECT SUMMARY
Structural plasticity of neuronal connections is crucial for the wiring and rewiring of
neuronal circuits in response to experience during development and in adulthood. Defects in
plasticity of neuronal connectivity underlie, exacerbate, or contribute to the pathogenesis of many
neurodevelopmental, neuropsychiatric, and neurological disorders, including age-related decline.
However, our understanding of the molecular control of structural plasticity across the lifespan
and in different neuronal contexts is far from complete, in part due to the lack of an experimentally
tractable system to study this complex process at this resolution. The well-defined nervous system
of the nematode Caenorhabditis elegans is an ideal system to identify the genes and molecular
mechanisms involved with direct comparison of multiple life stages. We propose to exploit a
robust model of structural plasticity we discovered in C. elegans to identify and compare
the genetic and molecular regulation of experience-dependent structural plasticity across
development, adulthood, and aging at single neuron resolution. In Aim #1, we will use the
power of C. elegans genetics to screen 20 conserved cell adhesion, scaffolding, and signaling
molecules for roles in experience-dependent structural plasticity during both development and in
early adulthood. Aim #2 will comprehensively characterize the impact of aging on a neuron,
circuit, and behavior in both sexes, and directly measure any changes in the capacity for structural
plasticity across adulthood and aging by inducing and inhibiting structural plasticity with opto- and
chemo-genetic tools. We will identify the mechanisms that maintain or degrade the capacity for
structural plasticity with age, providing novel characterization and understanding of structural
plasticity across the lifespan. In Aim #3, we will leverage the model of experience-dependent
structural plasticity in C. elegans to gain mechanistic insights into the role of multiple conserved
and disease-associated cell adhesion molecules in the regulation of structural plasticity. Using a
combination of transgenic rescue experiments and insertion of tags/tools into the endogenous
CAM genes, we will define the cellular, molecular, and temporal mechanisms by which CAMs
contribute to plasticity. The proposed experiments will directly contribute to our understanding of
the mechanisms and conserved genes that regulate experience-dependent structural plasticity.
thereby informing its role in brain health, disease, and aging, while potentially identifying novel
molecular targets for therapeutic intervention.

Public health relevance
PROJECT NARRATIVE Structural plasticity of neurons in the brain can rewire circuits during development, in response to experiences, injury, diseases, and aging, and is crucial for brain function and health. Our knowledge of the genes and mechanisms regulating structural plasticity between development, adulthood, and in aging is limited, in part due to technical barriers in studying this complex process in mammalian brains. We propose use of a robust model of experience-dependent structural plasticity in C. elegans to identify conserved genes and molecular mechanisms that regulate structural plasticity across the lifespan, which will provide fundamental knowledge about this understudied form of plasticity and potentially uncover novel therapeutic targets.